Development of a Mobile Health Personalized Physiologic Analytics Tool for Pediatric Patients with Sepsis

PROJECT SUMMARY
Sepsis is a life-threatening condition caused by an imbalanced immune response to infection, leading to organ
failure and death if untreated. Low- and middle-income countries (LMICs) bear a disproportionate burden of
childhood deaths due to sepsis resulting from acute infections like pneumonia, diarrhea, and malaria. Timely
recognition and treatment of sepsis in children are crucial for altering the disease course and preventing
mortality. There is immense potential for novel clinical tools that can expedite the identification of severe
sepsis, multiple organ dysfunction syndrome (MODS), and predict the highest mortality risk. These tools can
also effectively monitor treatment responses, decreasing the need for expensive laboratory diagnostics and
critical care monitoring equipment used in high-resource settings.
While early initiation of antimicrobial drugs is well-established in sepsis treatment, the guidance for
administration of intravenous fluids (IVF) for treatment of severe sepsis can vary depending on the
geographical region and even nutrition status. The 2020 Surviving Sepsis Campaign advises that children who
reside in areas with resource-limited healthcare systems receive lower initial fluid volumes based for sepsis
treatment based on a study with narrow generalizability that demonstrated increased mortality rates among
pediatric patients who received normal saline boluses for severe sepsis. Children with malnutrition and severe
sepsis are also fluid restricted.
This project aims to leverage predictive modeling and mobile health (mHealth) tools to evaluate the impact of
IVF administration on sepsis severity in pediatric patients. By utilizing machine learning models developed
under the parent award, real-time analysis of IVF effects on sepsis severity can be performed in LMIC settings.
Utilizing continuous vital sign parameters transmitted from a wearable device to a mobile phone, real-time
measurement of IVF impact on sepsis severity can be determined. This research can shed light on the benefits
or harms of fluid administration in LMIC children with severe sepsis, including specific populations like
malnourished children. Given the limited studies on appropriate fluid volumes for this subgroup, this research
offers an opportunity to determine safe and optimal fluid administration practices.
Through this research, we aim to contribute to the understanding of IVF administration effects on sepsis
severity in children, particularly in LMIC settings. The findings can guide fluid management practices, inform
tailored treatment strategies for malnourished patients, and improve outcomes for pediatric sepsis patients
worldwide.

Public health relevance
PROJECT NARRATIVE Children in low income countries are especially affected by sepsis, a dangerous condition caused by infection that can lead to organ failure and death. This project will use advanced technology to analyze real-time data from wearable devices to study how giving fluids through a vein affects the severity of sepsis in children in low resource settings. With this information, we can understand how fluids impact sepsis, develop better treatment strategies for it and improve outcomes for children with sepsis around the world.